Core B: Facility/Service Cores

Although mouse allergen and pollutant exposures have been linked to asthma morbidity in poor minority populations, these factors do not account for most of the observed morbidity, so that additional environmental factors almost certainly contribute to asthma morbidity in this population. One intriguing environmental factor is diet since the population that is most affected by asthma morbidity and mortalitypoor, predominantly African American populations- have a

Public health relevance
The DMSC serves a key support role, managing a very large amount of complex data from multiple studies These data span the spectrum from questionnaire data, clinical data, environmental exposure data, and biomarker data. The DMSC serves to ensure integration of all Projects.